Combination treatment of ischemic stroke with perlecan DV and neural stem cells

PROJECT ABSTRACT
Stroke, the fifth leading cause of death and leading cause of long-term disability in the United States, has
limited therapeutic options. Even with the advent of reperfusion therapies including tissue plasminogen
activator (tPA) and mechanical thrombectomy, extensive injury from stroke often results from ischemia-
reperfusion (IR), which damages the blood-brain barrier (BBB), the vessel network separating the brain from
the circulatory system. IR causes biphasic openings in the BBB, the first occurring within several hours of insult
and the second at 24-74 hours after stroke. The latter is generally irreversible and, thus, the most damaging.
Clinically, stem cell therapy offers great promise for treating stroke, but is currently aiming for stroke
rehabilitation by delivering cells during the recovery (not subacute) phase. Here, we propose a novel approach
to administer neural stem cells (NSCs) in the sub-acute phase to limit early-stage BBB injuries, an outcome
that would protect against the second phase of stroke damage.
We base this proposal on our extensive and novel preliminary and pilot data derived from a stroke mouse
model showing that human(h)NSCs transplanted into the brain 24h post-IR improves neurological function and
reduces BBB damage. Further, we have demonstrated that a protein fragment of the brain extracellular matrix
(ECM) component perlecan, termed domain V (DV), is neuroprotective after experimental ischemic stroke, and
may represent a promising new stroke therapy. Intriguingly, preliminary results also suggest that DV enhances
NSC survival and differentiation in to neurons in vitro. Therefore, in this study, we will test the hypothesis that
NSCs, in combination with the neuroprotective and neuroreparative protein perlecan DV, will
synergistically ameliorate pathophysiology and neurological outcome in stroked mice. Ameliorating
BBB damage before NSC transplantation using a neuroprotectant DV will improve the brain environment for
NSC survival and allow for greater NSC efficacy. We will employ a filament MCAO/reperfusion (IR injury)
mouse model that mimics ischemic stroke injuries seen in patients. Since aging is a strong risk factor for stroke,
we will use both young adult and aged female and male mice, in whom neurobehavioral deficits are found to
be worse. Aim 1 will determine the effects of neural stem cells and DV co-administration on sub-acute stroke
injury in young adult and aged mice. Aim 2 will determine the effects of sub-acute neural stem cell delivery
and DV co-administration on neuro-repair and long-term stroke recovery. Aim 3 will investigate the direct effect
of perlecan DV in mechanisms of a2b1-induced NSC neuronal differentiation in vitro.
This study is significant because it will generate new preclinical data that demonstrate the optimal strategy for
NSC treatment, coupled with a novel neuroprotectant for ischemic stroke. The study will use innovative
methods by employing and combining adjuvant pharmacological treatment (neuroprotectant) with NSCs, to
improve stroke outcome.

Public health relevance
PUBLIC HEALTH RELEVANCE Stroke is a leading cause of death in the United States (U.S.). The only available drug approved by the U.S. Food and Drug Administration (FDA) for treatment of ischemic stroke is thrombolytic tissue plasminogen activator (tPA). Reperfusion therapies including mechanical thrombectomy restore blood flow, but it has a greater risk of destabilizing the blood-brain barrier. Also, aging is a major risk factor for stroke and we live in an aging nation with more than 45 million Americans aged 65 and older. By 2060, these numbers will likely double. Thus, new therapies are needed to lessen stroke’s harmful effects and quickly facilitate vascular repair. The proposed research is aimed at studying the beneficial role of early administration of neural stem cells (NSCs) in repairing blood vessels and brain tissue after stroke and improving long-term stroke recovery. Further, we will test whether NSCs, in combination with a neuroprotectant, will synergistically improve stroke outcome.